Implementation of PrEP for Women Who Inject Drugs through Practice Facilitation in Primary and Reproductive Health Care

PROJECT SUMMARY/ABSTRACT: The goal of this research is to prevent HIV among women who inject
drugs (WWID) through organization-level change in the way pre-exposure prophylaxis (PrEP) is delivered to
this population. Dr. Starbird is proposing a research and career development plan which will prepare her to
independently evaluate system-level interventions to improve care delivery to WWID with high capacity for
implementation. WWID are among the most vulnerable to acquiring HIV due to the dual effects of both unsafe
injecting and sexual practices. PrEP is effective and recommended to prevent HIV infection among high-risk
groups, including WWID. However, PrEP uptake among WWID is lagging – 92% of people who receive PrEP
in New York State are men. Interventions at the organizational level present an opportunity to improve PrEP
delivery and decrease gender disparities among people who inject drugs, particularly in primary and
reproductive healthcare settings which can engage WWID in ongoing PrEP use when they present for
comorbidity management, psychosocial services, or pregnancy support. Including PrEP for WWID in often
under-resourced and stretched primary and reproductive healthcare settings poses organizational challenges
that may be eliminated with Practice Facilitation. Practice Facilitation is an evidence-based strategy to support
clinics' abilities to implement an intervention such as PrEP through technical assistance, logistical support, and
external partnership building. This study will leverage NIDA's investment in the HEALing Communities Study in
New York State (UM1 DA049415, PI: El-Bassel, mentor) to achieve the following specific aims: 1) explore the
opinions of WWID about how PrEP is delivered to them, 2) examine the provider- and organization-level
barriers and facilitators to delivering PrEP to WWID, and 3) adapt and pilot test the feasibility and acceptability
of Practice Facilitation to improve PrEP delivery to WWID in primary and reproductive healthcare settings. We
hypothesize that PrEP Practice Facilitation will be feasible and acceptable to primary and reproductive
healthcare organizations and demonstrate potential to increase the proportion of WWID who receive a
prescription for PrEP. Dr. Starbird has contributed to understanding the efficacy, effectiveness, and economic
implications of interventions for individuals with substance use disorder, HIV, and hepatitis C. This Mentored
Research Scientist Development Award builds on this experience and extends it with training in four key skills:
1) advanced qualitative analysis, 2) organizational behavior change, 3) implementation science, and 4) ethical
conduct of research with vulnerable women. The proposed K01 will provide training, mentorship, and research
experience that will serve as the foundation for Dr. Starbird's career as an independent investigator dedicated
to improving healthcare delivery for marginalized populations. This project is well-aligned with the strategic
objectives of NIDA and also directly in line with the Office of AIDS Research cross-cutting areas of Health
Disparities and Implementation Science Research to reduce the incidence of HIV.

Public health relevance
PROJECT NARRATIVE Women who inject drugs are among the most vulnerable to acquiring HIV, but very few women who inject drugs are prescribed pre-exposure prophylaxis (PrEP) for HIV prevention largely due to barriers within our healthcare system. This research will consider the perspectives of women who inject drugs, healthcare providers, and clinic leadership to improve the way primary care and reproductive health clinics deliver PrEP to women who inject drugs, thereby reducing new HIV infections in this population. The research and training in this application will prepare the candidate for an independent scientific career conducting intervention research among vulnerable populations with high capacity for real-world implementation and dissemination.